Integrators of Metastatic Potential

ABSTRACT
One key goal of the NCI Precision Medicine Initiative focuses on development of new tools to tailor cancer
therapy to disease status and risk of metastasis-- Patients at high risk for metastatic disease would receive
aggressive, frequently molecularly-targeted therapy, whereas those with low risk for metastatic disease would
be treated with appropriate local therapies, sparing them toxic side effects of therapy while maintaining high
likelihood for cure. One of the main challenges preventing implementation of precision medicine for metastasis
is limited understanding of signaling molecules and pathways that confer high metastatic potential to a small
subset of cancer cells within a larger, heterogeneous tumor. Consequently, molecular imaging of metastatic
‘potential’ is an unvanquished challenge.
To engineer biosensors that can detect and measure metastatic 'potential' of single living cancer cells,
we carried out a comprehensive analysis of the pan-cancer phosphoproteome to search for actin-remodelers
required for cell migration, that are enriched in cancers, but excluded in normal cells. Only one phosphoprotein
emerged, tyr-phosphorylated CCDC88A (GIV/Girdin), a bona-fide metastasis-related protein across a variety of
solid tumors. We designed multi-modular biosensors that are partly derived from GIV, and because GIV
integrates pro-metastatic signaling by multiple oncogenic receptors, we named them ‘Integrator-of-Metastatic-
Potential (IMP)'. It is hypothesized that single cell imaging of GIV activation using IMPs, rather than simply
levels of GIV expression, will detect the subset of metastasis-initiating cells that must be eliminated to prevent
metastatic disease. Preliminary experiments demonstrate that IMPs captured the heterogeneity of metastatic
potential within primary lung and breast tumors at steady-state, detected those few cells which have acquired
the highest metastatic potential and tracked their enrichment during metastasis. These findings provide proof-
of-concept that IMPs can measure the diversity and plasticity of metastatic potential of tumor cells in a sensitive
and unbiased way. Going forward, IMPs will be optimized and validated for use as tools for molecular imaging
of metastasis-initiating cells via 3 goals: 1) Image metastatic potential of single breast cancer cells; 2) Image
GIV activation as a marker of Metastasis Initiating Cells (MICs); and 3) Image metastatic potential in patient-
derived xenografts. To accomplish these goals, this multi PD/PI proposal capitalizes on synergy of non-
overlapping expertise of two PIs and two animal model systems (zebrafish and mice), in-depth biology of a novel
signaling pathway, and cutting-edge technology of in vivo imaging.
Success in detecting metastasis-initiating cells will be a transformative advance for cancer cell biology.
It will pave the path for the development of personalized screening platforms to assess the effectiveness of anti-
cancer drugs in killing the highly tumorigenic cells within any given tumor, and ultimately enable clinical
implementation of precision cancer therapy to improve treatment and quality of life for patients.

Public health relevance
PROJECT NARRATIVE Most cancers would not be fatal if they did not spread (metastasize); the greatest damage is caused by a few tumorigenic cells have the potential to metastasize, i.e., they can escape the tumor environment, enter blood stream, evade the immune system and chemotherapy drugs, seed elsewhere in the body and successfully nucleate a metastatic tumor; finding those most sinister cells before they have spread has been an unrealized goal. This proposal seeks to develop, synthesize, select, optimize, and validate novel fluorescent biosensors/ probes to detect and measure the 'potential' for metastasis of single living cancer cells. Successful development of these probes are expected to allow personalized screening platforms to assess effectiveness of novel chemotherapy agents selectively against the highly tumorigenic cells within any given tumor.